Transdisciplinary Training in Sleep and Circadian Rhythms

ABSTRACT
The primary aim of this new University of Colorado transdisciplinary training program is to prepare outstanding
pre-(PhD) and post-(PhD, MD/PhD, MD) doctoral fellows for science careers that address cutting-edge basic
and clinical research questions that represent the future of biomedical research. The training program will
foster transdisciplinary research with state-of-the-art technologies and methods used by participating faculty
laboratories, and will evaluate and enhance the mentoring skills of early career faculty. The program is novel in
that it exposes trainees and faculty from diverse biomedical research backgrounds to collaborative sleep and
circadian science. Similarly, current sleep and circadian trainees and expert faculty benefit from meaningful
interactions with investigators from different research backgrounds, particularly those from biomedical research
areas that are of high importance to the NIH/NHLBI. The research training activities of the 22 participating
faculty emphasize transdisciplinary training in sleep and circadian physiology with research programs focused
on cardiovascular, genetics/genomics, metabolomics, proteomics, biomarker development, bioinformatics,
biostatistics, epidemiology, stress physiology, immunology, endocrinology, metabolism, obesity, diabetes,
neuroscience, pediatrics, development, aging, psychiatry, and pulmonary and behavioral sleep medicine.
Because our goal is to provide transdisciplinary and translational research career training, major program
components of this T32 include the Department of Integrative Physiology, the Department of Psychology and
Neuroscience, and the Institute for Behavioral Genetics at University of Colorado Boulder, and multiple clinical
departments and divisions at University of Colorado School of Medicine Anschutz Medical Campus. The
existing fruitful and collaborative environment is a strength of this training grant. Of the existing T32s at the
University of Colorado, this would be the only one dedicated to transdisciplinary sleep and circadian science.
Also, it would become the first sleep and circadian T32 in the Western United States.
The specific aims of the training program are to recruit, select and retain outstanding trainees; promote
inclusive excellence; provide high quality training, educational, and career development experiences to prepare
trainees for research-intensive and research-related careers; shape tomorrow’s scientific leaders; foster
rigorous and collaborative sleep and circadian science; ensure successful progress of trainees toward
predetermined milestones defined in Individual Development Plans; enhance the mentoring skills of faculty
through a formal mentoring training plan; ensure conscientious program evaluation; and expand the number of
investigators conducting transdisciplinary sleep and circadian science. We request support for one pre-doctoral
and one post-doctoral trainee in year 1, and two pre-doctoral and two post-doctoral trainees in years 2-5.

Public health relevance
Public Health Relevance Insufficient sleep and circadian dysregulation cause, promote and exacerbate major medical health problems such as cardiovascular disease, obesity, diabetes, depression and respiratory disorders. The number of investigators being trained in transdisciplinary sleep and circadian research cannot keep pace with the accelerating health-care problems associated with insufficient sleep and circadian dysregulation. This training program will increase the number of researchers in the pipeline and facilitate the development of the next generation of scientific leaders; and thereby, this training program will ultimately contribute to knowledge of integrative physiological mechanisms and the treatment of disease that will advance the health and well-being of the public.